PDB MANAGEMENT BY THE RESEARCH COLLABORATORY FOR STRUCTURAL BIOINFORMATICS

PROJECT SUMMARY
The mission of the Research Collaboratory for Structural Bioinformatics Protein Data Bank (RCSB PDB) is to
sustain a unique Findable-Accessible-Interoperable-Reusable living data resource of three-dimensional (3D)
biomolecular structure information. PDB structures are the molecules of life. Knowledge of 3D structures
(shapes) of biological macromolecules, how they evolved with time, and their functions are essential for
understanding critical areas of science, including fundamental biology; health and disease of humans, animals,
and plants; food and energy production; and other topics of concern to global prosperity and environmental
sustainability. Structure data are equally important for biopharmaceutical and biotechnology companies, driving
discovery of new therapeutics, biomaterials, and medical devices. RCSB PDB services span the entire PDB data
lifecycle, encompassing Deposition/Biocuration, Archive Management/Access, Data Exploration, and
Outreach/Education. RCSB PDB Archive Management/Access services safeguard the single global archive of
>144,000 3D structures of biological macromolecules, with an estimated replacement cost of nearly $14 billion.
RCSB PDB Deposition/Biocuration and Data Exploration services support >30,000 Data Depositors and >1
million Data Consumers worldwide. More than 620,000 researchers, educators, students, and members of the
public use our award winning Outreach/Education Services.
During 2019-2023, the RCSB PDB has three Specific Aims. Successful completion of these Specific Aims will
entail further investments in cloud computing/storage, considerable software engineering, and modest
recruitment of additional personnel to address three overarching challenges that confront the organization.
Specific Aim 1: Scale RCSB PDB operational capabilities to meet projected growth in (i) new structures;
(ii) average structure size and complexity; (iii) annual data download volume; and (iv) Users and User
communities, and diversity thereof. Specific Aim 2: Scale RCSB PDB operational capabilities to meet projected
growth in structure data and complexity coming from studies of molecular machines using two rapidly evolving
experimental methods (serial femtosecond X-ray crystallography or SFX and 3DEM) that have already eclipsed
some of our service capabilities. Specific Aim 3: Implement deposition-validation-biocuration, archiving, and
online delivery/tooling for structure data from emerging structure determination methods that combine 3DEM
and/or macromolecular crystallography with multiple measurement techniques not currently supported in the
PDB. These Integrative/Hybrid Methods structures are in the vanguard of cell/organismal biology research.
Continued access to PDB data and RCSB PDB Services will drive publication of innovative research across the
biomedical sciences, drug discovery and development, patent applications, and innovations leading to discovery
and development of life-changing biopharmaceutical products and formation of new US companies.

Public health relevance
PROJECT NARRATIVE The RCSB Protein Data Bank (PDB) supports open access to an enormous wealth of public domain biomolecular structure information, provided in the context of biological function, biochemical pathways, cellular processes, disease states, and molecular evolution. This information is delivered to more than 1 million unique Users in the US and around the world every year, leveraging RCSB PDB data exploration tools that are tailored to both basic and applied researchers (via rcsb.org) and educators and students (via pdb101.rscb.org). PDB data and RCSB PDB services foster understanding of fundament biology, biomedicine, and energy, and enable discovery of life- changing new drugs targeting disease across all therapeutic areas.